Proteoglycan regulation of tumor angiogenesis and endothelial cell autophagy

Chief among female mortality is the development, progression, and metastasis of aggressive breast cancer. The
bidirectional communication between the neoplastic cells and the tumor microenvironment, which supplies
oxygen and nutrients, is essential for promoting unchecked tumorigenic development, aberrant
neovascularization, and widespread metastasis. Thus, a better understanding of embedded cues and soluble
messages exchanged between these two compartments will prove invaluable for furthering our knowledge of
the pathobiology of cancer and for reliably predicting clinical outcomes.
Our central hypothesis is that endorepellin, a proteolytic fragment of perlecan, a multi-domain heparan sulfate
proteoglycan, exploits a dual-receptor antagonism to preclude endothelial cells from participating in tumor
angiogenesis. This working hypothesis is based on an impactful and promising body of work all generated under
the auspices of this grant. We discovered that: [a] Endorepellin simultaneously ligates, with high affinity,
VEGFR2 and the 21 integrin thereby constituting the molecular basis of “dual receptor antagonism”.
Engagement of both receptors underscores the exquisite sensitivity and specificity of endorepellin in targeting
the endothelia. [b] Endorepellin triggers co-internalization of VEGFR2 and 21 integrin with concurrent
activation of the SHP-1 tyrosine phosphatase and attenuation of VEGFA signaling. [c] Endorepellin induces
endothelial cell autophagy in a Peg3-dependent manner by modulating Beclin 1, LC3, and p62 expression,
processing, and cellular localization. [d] Endorepellin evokes protracted activation of the energy-sensor kinase
AMPK, irrespective of energy levels. Indeed, this regulation is considered non-canonical as AMPK
phosphorylation occurred under nutrient-enriched conditions. [e] Downstream of AMPK, endorepellin evokes
autophagic flux in endothelial cells that mechanistically parallels the mTOR inhibitor, Torin 1. These striking
findings demonstrate that protracted and sustained autophagy is a novel mechanism by which endorepellin
promotes angiostasis, independent of nutrient deprivation. Based on these discoveries, we plan to:
[1] Elucidate the mechanism of endorepellin-evoked endothelial cell stress, autophagy and mitophagy.
[2] Unravel the mechanism by which endorepellin induces autophagic suppression of HAS2.
[3] Generate novel mouse models of tumorigenesis to explain the pro-autophagic and anti-angiogenic programs
activated by endorepellin.
These concerted research aims will enable us to translate our findings, procured with highly innovative mouse
models of stromal autophagy, into clinically relevant paradigms. The discovery of endorepellin-induced
endothelial cell autophagy downstream of dual receptor antagonism will lead to new therapeutic advances that
actively induce autophagy within the tumor microenvironment to combat this devastating disease.

Public health relevance
We discovered that endorepellin, a soluble fragment of the heparan sulfate proteoglycan perlecan, evokes excessive autophagy or self-eating in the endothelial cells lining breast cancer vessels with no direct effects on the cancer cells. This novel bioactivity of endorepellin, via selective and specific targeting of the endothelia, will be investigated utilizing state-of-the-art molecular methodologies combined with highly-innovative mouse models of mammary carcinomas. Our research, by focusing on the tumor microenvironment and tumor secretome, will unravel unique avenues of study using endorepellin as a valuable treatment modality to combat this devastating disease in both primary and secondary malignancies.